High density chronic optogenetic interface for primate brains

PROJECT SUMMARY
Understanding the function of neural circuits in the cerebral cortex of the non-human primate (NHP), the model
system closest to human, is crucial to understanding normal cortical function and the circuit-level basis of human
brain disorders. Optogenetics has become a powerful tool for studying neural circuit function, but challenges
remain in its application to NHPs. Large volume manipulations are essential in the large NHP brain in order to
observe measurable electrophysiological or behavioral effects and understand the encoding of information across
multiple brain areas. Under previous NIH BRAIN Initiative funding, an interdisciplinary team led by the
University of Utah has developed and tested in vivo the Utah Optrode Array (UOA). This is a 10x10 array of
penetrating transparent light guides, bonded to a µLED array, for large-volume, spatiotemporally patterned
optogenetic modulation of neural circuits in large brains. In vivo testing of the UOA in NHP visual cortex
demonstrated that the device allows for selective activation of deep cortical layers, as well as for both focal and
large-scale photostimulation by simply varying the number of simultaneously activated µLEDs and/or their light
irradiance These results establish the UOA as a powerful tool for studying local and large-volume targeted
neuronal populations in large brains. Led by Blackrock Neurotech, the goal of this STTR is to transition the UOA
into a commercializable device by combing the best features of its current ‘LED Stim’ optogenetic surface
stimulation array with the UOA. Thus, the goal of Phase I is to engineer the first iteration of this new device,
termed ‘OA2’ for development purposes: Aim 1: Integration of blue stimulation array, in which redesign,
fabrication, and integration of the two-level stimulation device will be performed using independent 10×10 and
9×9 arrays of blue µLEDs for deep-layer and surface stimulation, respectively. Aim 2: Device encapsulation and
packaging, in which robust encapsulation processes will be developed and tested, suitable for acute in vivo use.
Aim 3: Development of matrix driver, in which a new driver and firmware will be developed in order to
independently control the deep and surface stimulation arrays for spatially-multiplexed operation. The project
includes a Go-NoGo to phase II paradigm which requires >90% of the stimulation sites to remain active >2.8
mW/mm2 following acute soak testing with 50% simultaneous operation at 10% duty cycle, artifact-free. Phase
II will consist of four Aims: Aim 4: Device optimization for multi-color stimulation, in which the active µLED
component will be modified to facilitate placement and hard encapsulation of µLEDs onto the topside of the
device, allowing multi-color stimulation at each deep/surface site. Both single and two-color devices will be
produced in Phase II. Aim 5: Device encapsulation and packaging, will build upon the work of Aim 2 to include
hard encapsulation of the active components of the device in order to increase device in vivo reliability. Processes
will be developed and tested suitable for chronic in vivo use. Aim 6: Development of dual-color matrix driver, in
which the matrix driver will be updated to bipolar drive signals to enable multiplexed control of two µLEDs per
stimulation site. Aim 7: In vivo testing in NHP, in which both acute and chronic testing of the OA2 device will be
performed in macaque for periods up to 6 months.

Public health relevance
NARRATIVE Normal brain function depends on the orderly development of circuits in the cerebral cortex and on their intact function. The novel technology that will result from the work proposed in this application will allow for unprecedented optogenetic investigations of the function of specific cortical circuits in non- human primate brain. Understanding how cortical circuits operate in the normal brain will provide a foundation for understanding the consequences of their dysfunction in disorders of brain function such as autism and schizophrenia, which have been directly linked to abnormalities in inter-areal connectivity. Our technology will also open the possibility for a new generation of precise neurological and psychiatric therapeutic interventions via cell type specific optical neural control prosthetics to restore lost cortical function, or for treatment of neurological disorders such as epilepsy. One of the key factors impeding the development of medical applications of optogenetics in humans has been the difficulty of applying this method to non-genetically tractable species and to large brains such as those of primates. The present proposal specifically tackles these problems and, therefore, will have an important positive impact in the future development of optogenetics for medical applications in humans.